Immune Monitoring and Flow Cytometry Shared Resource

PROJECT SUMMARY: IMMUNE MONITORING & FLOW CYTOMETRY SHARED RESOURCE
The Immune Monitoring and Flow Cytometry Shared Resource (IM&FCSR) of the Fred Hutch/University of
Washington/Seattle Children’s Cancer Consortium provides Consortium members with services and research
expertise supporting a wide range of laboratory and clinical studies in cancer immunology, immunotherapy,
transplant biology, infectious disease, and vaccine development. Co-directed by Jianhong Cao, PhD (Immune
Monitoring Lab-IML) and Michele Black (Flow Cytometry-FC), IM&FCSR supports critical translational and
clinical research such as the characterization of immune cell phenotypes, persistence, and functionality in
response to immunotherapies. IM&FCSR’s mission is to 1) enable cancer immunotherapy research and clinical
trials by providing cutting-edge instrumentation to analyze cell types and their functions 2) ensure researchers
have access to technical expertise and superior experimental design support for customized, multiparameter
flow cytometry panels and unique immune assays 3) provide high quality customer service and 4) educate
Consortium users in use of flow cytometry equipment and immune-assay related research to optimize data
quality and reproducibility. Specific services provided by IML include production of custom-made peptide
loaded major histocompatibility complex (pMHC) tetramer reagents to assess and isolate antigen-specific T
cells for clinical research and therapy trials. IML also provides deep sequencing of T cell receptors and
analysis of cytokines at high multiplicity, ultra-sensitivity, and single cell base. FC offers a wide range of
instruments, from basic to full spectrum analyzers, CyTOF mass spec analyzers, and cutting-edge multi-laser
high parameter cell sorters. Both teams provide data evaluation and interpretation, assistance in optimizing
experimental design, hands-on technical assistance, and training. Since the last renewal, the IM&FCSR has
expanded its overall new laboratory space by 1,500 sq ft, increasing service and instrumentation capability and
capacity. Flow cytometry service was expanded by a total of eight new cytometers including two Becton
Dickinson (BD) Symphony™ A5 SE analyzers, a Sony ID7000 and Cytek Aurora full spectrum analyzers, and
two BD Symphony™ S6 cell sorters. IML added a z-Movi Cell Analyzer, a novel instrument measuring cell
affinity. Both laboratories upgraded biocontainment equipment and practices to process BSL-2 samples.
IM&FCSR also launched a new outreach and educational initiative for members of the Consortium community
regarding its services and technologies. IM&FCSR is committed to providing cost-effective and timely access
to its services and instrumentation. Over the next grant period, we will add other molecular assay based on
digital PCR and expand our pMHC tetramer service, particular Class-II tetramers. FC will add the first of its
kind BD Discover S8 with Cell View imaging cell sorter. We are partnering with Shared Resources
Management to implement Cirro, a new secure cloud-based data management and data analysis pipeline.
IM&FCSR will continue to upgrade and add instruments as research requires and the technology advances.